Self-calibrated ionophore-based ion-selective electrodes for at-home measurements of blood electrolytes

SUMMARY
Measurements of electrolytes in body fluids are essential for diagnosing and managing many chronic heart,
kidney, parathyroid, and nerve disorders. Ion-selective electrodes have been routinely used for electrolyte
measurements in clinical chemistry analyzers and blood analyzers in hospitals since the 1980s. However,
patients with conditions such as hypoparathyroidism, heart failure, bipolar disorder, and end-stage renal disease
often need to monitor their electrolytes much more frequently than allowed by hospital visits. It is an even bigger
problem for disabled, elderly, and low-income patients as well as patients living in rural and underserved areas.
The past decade has witnessed a surge of interest in accessible and affordable electrolyte monitoring based on
home-use sensors, wearable sensors, transdermal sensors, and implantable sensors. However, ion-selective
electrodes are only accurate when calibrated with a standard solution at the point of use. All centralized,
benchtop, and handheld instruments with ion-selective electrodes use pumps or actuators to handle calibration
solutions and samples via complicated fluidic systems. Because this technically demanding calibration procedure
cannot be implemented in the low-cost and compact sensors on the body or at home, these emerging sensors
cannot generate reliable data for medical decisions. Therefore, calibration has been a fundamental bottleneck
for translating new electrolyte monitoring modalities into healthcare practice.
This project aims to develop a completely new calibration strategy for ion-selective electrodes without using any
moving parts or fluidics. A narrow calibration phase is built in between the working and reference electrodes to
provide a baseline potential that serves as a one-point calibration. Surprisingly, the calibration bridge does not
need to be removed for the sample testing because the sample dominates the interfacial charge transfer and
the potentiometric signal. This highly unique built-in calibration method does not increase the complexity,
footprint, cost, and sample volume of the electrolyte sensors and, therefore, enables their use for low-volume
samples in decentralized settings. This R21 grant will focus on home-use Ca2+ and K+ selective sensors because
of the urgent and overlooked need for at-home monitoring of these electrolytes from capillary blood. In Aim 1,
we will use 3D printing and microfabrication techniques to prepare all-solid-state self-calibrating sensors that are
portable, transportable, stable, and mass-producible. In Aim 2, we will determine the analytical performance
characteristics of these sensors and validate their accuracy and precision in human blood samples against a
commercial blood analyzer. This exploratory grant will allow us to confirm the feasibility of the self-calibration
concept in home-use sensors using Ca2+ and K+ as the example analytes. In future work, we will adopt this
concept in sensors toward more and multiple electrolytes in various decentralized settings. The ultimate goal is
to empower patients to monitor electrolyte concentrations in a frequent and minimally invasive manner for their
self-management of chronic diseases.

Public health relevance
NARRATIVE Patients with electrolyte disorders require adequate monitoring of blood electrolytes for optimal dosing of medications and early identification of potential complications. The proposed self-calibrated ion sensors will empower them to measure electrolytes at home using only a drop of blood collected from a fingerstick. At-home electrolyte monitors are expected to revolutionize the self-management of a wide range of chronic heart, kidney, and parathyroid diseases similarly as the glucose meter has done for the diabetes management.